Educational Toolkit for Bioengineering Design, Entrepreneurship and Service Learning

PROJECT SUMMARY
The "Educational Toolkit for Bioengineering Design, Entrepreneurship and Service Learning”
parent award has focused on enhancing the biomedical engineering education by implementing several
additional curricular components in team-based courses that include clinical needs finding,
entrepreneurial bioengineering, capstone senior design and biomedical innovations for global impact.
Through this supplement award, we propose additional work to enhance excellence in Diversity, Equity,
Inclusion and Accessibility (DEIA) Mentorship. Specifically, we will focus our efforts on promoting (a)
mentoring students from diverse backgrounds (b)enhancing DEIA within the biomedical engineering
curriculum and (c) leadership experiences for mentees and (d) community engagement to promote
biodesign and service learning.
If the goals of the proposed DEIA activities are met, students will gain valuable understanding
about the role of a biomedical engineer in the world around them, possess an understanding about design
and commercialization in an engineering context, but are sensitive to aspects beyond science, such as
health disparities and ethical challenges. Furthermore, by emphasizing the community engagement
aspect in the different courses as part of the educational toolkit, we are encouraging the students to be
the best possible stewards of their education, in growing to serve the communities around them, and
inspiring the younger generation of engineers.

Public health relevance
PROJECT NARRATIVE We are transforming our biomedical engineering education by introducing series of courses as part of an educational toolkit for bioengineering design, entrepreneurship, and service learning into our curriculum. In an inclusive learning environment, students will engage with our local healthcare community to identify healthcare gaps and disparities and inspire the next generation of engineers by mentoring high school pre-engineering students. Our aim is to graduate biomedical engineers who are outstanding stewards of their education, serving their communities, and translating healthcare innovations for a broader impact.